Cerebral Amyloid Angiopathy and Related Cerebral Microvasculopathies

DESCRIPTION (provided by applicant): This application seeks support for a conference entitled Cerebral Amyloid Angiopathy and Related Cerebral Microvasculopathies to be held November 12-14, 2009, at the Ronald Reagan UCLA Medical Center and David Geffen School of Medicine in Los Angeles, CA. The conference will seek to recruit clinical and basic scientists currently active in studying cerebral amyloid angiopathy as well as leading investigators from related fields such as the non-amyloid cerebral microangiopathies (including cerebroretinal vasculopathies, CADASIL) and amyloid immunotherapy, including individuals with expertise in biomarkers. A special effort will be made to include promising clinical and basic junior scientists. The Cerebral Amyloid Angiopathy and Related Cerebral Microvasculopathies conference will focus on recent developments in areas such as amyloid angiopathyrelated microbleeds and other biomarkers, animal models, the non-amyloid angiopathies, and the relation between amyloid angiopathy and anti-amyloid immunotherapeutic approaches to Alzheimer disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Stroke is currently the second leading cause of death in the Western world, ranking after heart disease though before cancer, and causes an estimated 10% of deaths worldwide. Even individuals who survive a stroke are often left with significant neurologic disability, sometimes to the point of requiring supportive care for the duration of their lives. A significant number of hemorrhagic stroke are attributed to cerebral amyloid angiopathy (CAA), an abnormality that affects small blood vessels within the brain, increasing with advancing age. Our conference will provide insights into new data and hypotheses, as well as ongoing or emerging controversies in understanding CAA, bringing together clinicians and basic scientists with an interest in this important and very common entity. This conference has the potential to greatly impact the manner in which we view CAA and possibly other causes of stroke and/or dementia, and reduce morbidity and mortality related to it, among US citizens.